Core--Training

Description (provided by applicant): This core will provide support to the CIPRA Cores and Research Projects at both the central and field site levels, including financial management, organization of meetings and conferences, human resources oversight, maintenance of key study documentation and correspondence, and other support mechanisms; and it will also coordinate and facilitate in-country and international training programs to strengthen the skills of Chinese HIV/AIDS researchers within the CIPRA program.